Predoctoral Training of Neuroscientists

This proposal is for a new training grant under the Jointly Sponsored NIH Predoctoral Training
Program in the Neurosciences (JSPTPN) at the University of Minnesota. Although a new
application, this proposal is effectively a continuation of the University of Minnesota's highly
successful NIGMS training program, “Predoctoral Training of Neuroscientists” (T32-GM08471,
1993-2018) under the Systems and Integrative Biology Program. Trainees in this program are
pursuing a PhD through the Graduate Program in Neuroscience at the University of Minnesota,
an interdepartmental and interdisciplinary program that spans 30 departments. The program
provides select trainees added value in the first two years of their graduate careers, providing its
trainees with a broad foundation in neuroscience as well as the interdisciplinary skills needed to
be successful within their neuroscientific careers. In particular, the program is designed to
provide a broad understanding of the field as well as a deep understanding of research
methodologies, experimental design, and quantitative reasoning. This program is built around a
core of didactic coursework in neuroscience, exposure to research-related issues such as
ensuring rigor and reproducibility and quantitative analyses, and the beginning of thesis-related
in-depth research projects. Flexibility and time for in-depth development of collateral fields of
knowledge are provided. Several unique educational opportunities are included, including the
long-running Itasca summer laboratory, rotations, and specific classes in rigor, reproducibility,
and quantitative reasoning. Time and attention are given to the student's professional
development, including exposure to neuroscience at the national and international levels. A
talented group of trainers have been assembled that reflects the diversity of research questions,
areas of study, and techniques in neuroscience. Each trainer directs a productive research
program and has demonstrated commitment to teaching and training. The trainers are united
by their participation in the Graduate Program in Neuroscience and by their dedication to
predoctoral training. An impressive array of scientific and institutional resources are available
to the trainees, including substantial direct institutional support for this training grant. The
graduates of this program will be trained to be independent researchers, capable of making
contributions in academia, teaching, industry, government, and public service.

Public health relevance
Success in the field of neuroscience requires a broad understanding of the field as well as a deep understanding of research methodologies, experimental design, and quantitative reasoning. This program will provide its trainees with a broad foundation in neuroscience as well as the interdisciplinary skills needed to be successful within their neuroscientific careers. The students will be trained to be independent researchers, capable of making contributions in academia, teaching, industry, government, and public service.